CHEMISTRY SUPPORT SERVICES--NATIONAL TOXICOLOGY PROGRAM

Provides continuous chemistry support services for the National Toxicology Program to include chemical procurement, bulkchemical characterization, and dosed vehicle preparation and analysis.